Vermont Center for Cardiovascular and Brain Health

PROJECT SUMMARY
Cardiovascular disease is the #1 cause of mortality in the United States and stroke is the #5 cause. Stroke is
also the #1 cause of disability, and it, along with covert neurovascular disease including small vessel disease
of the brain, leads to Vascular Cognitive Impairment and Dementia (VCID). Each year 800,000 Americans have
a stroke and 720,000 Americans have myocardial infarction. There will be 75 million people with dementia by
2030 and 131 million by 2050. Direct annual costs of cardiovascular disease and stroke are $318 billion and
dementia $277 billion. The American Heart Association issued a Presidential Advisory in 2017 highlighting the
central role of cardiovascular health to brain health and cognitive function. Much of VCID is driven by increases
in covert stroke and small vessel disease of the brain, research areas of expertise for the PIs of this
application. To address these issues, this University of Vermont (UVM) Center on Cardiovascular and Brain
Health (VCCBH) will leverage NIH funding and institutional commitment to convene multidisciplinary
researchers across career stages to determine causes and suggest optimal treatments for cardiovascular and
neurovascular disease, including stroke and VCID. We have selected four junior faculty (Project Directors,
PDs), from three departments and two UVM colleges, through a rigorous selection process. The VCCBH will
support the PDs' transition to independence using a Strategic Mentoring Initiative (SMI), Faculty Development
Program (FDP), and assistance and education from two new Core facilities. The SMI will employ
multidisciplinary Mentor Teams, including Peer Mentors. The FDP will comprise several educational programs
highlighted by an annual 2-Day Research Symposium, and an impactful Pilot Grant program (supported by
institutional commitments) that will provide $200,000 to four interdisciplinary research teams of junior faculty.
We will establish two new Core facilities: Study Design and Molecular Epidemiology, and Customized
Physiology and Imaging. A pipeline of new project directors will be developed from a pool of 19 current
candidates and five new junior faculty, who will be recruited with committed institutional support. Capstones of
the Center will include continual quality evaluation, clear communication and commitment to diversity. By the
completion of Phase I of funding, the Center will be on a strong path to sustainability in research excellence.

Public health relevance
NARRATIVE Cardiovascular disease and stroke are the leading causes of death and disability in the United States, and are intimately related to cognitive impairment and dementia. Cardiovascular disease is not simply a disease of the heart or blood vessels, but rather it impacts every organ. We propose a Center of Biomedical Research Excellence (COBRE), the “Vermont Center on Cardiovascular and Brain Health” (VCCBH) that will nucleate the University of Vermont's considerable research expertise in cardiovascular and neurovascular research to address these issues from diverse, mutually reinforcing basic science, clinical science and epidemiology perspectives. While advancing science, the Center will support the transition of early career faculty to independent scientists.